Subcellular-targeted CYP2E1 and alcohol in the brain

PROJECT SUMMARY
Metabolism of alcohol (i.e., ethanol) to acetaldehyde within different brain regions and in different subcellular
compartments, and how that metabolism changes with chronic ethanol use, is not well-understood. The long-
term goal is to identify adaptive changes that occur in chronic ethanol abuse and to identify therapeutic
strategies to prevent or reverse neurological damage from ethanol. The objective of this proposal is to
determine subcellular regulation of ethanol metabolism in mitochondria and endoplasmic reticulum (ER) by
CYP2E1 during acute and chronic ethanol use, and to determine the consequences of the differential targeting.
The central hypothesis is that targeting of CYP2E1 to mitochondria will be increased during chronic alcohol use
in some regions of the brain that are sensitive to ethanol-induced damage, and that high mitochondrial
targeting will drive high mitochondrial acetaldehyde production and resulting mitochondrial dysfunction and
oxidative stress. The rationale underlying this hypothesis is that CYP2E1 expression overall is increased in
brain regions that are sensitive to ethanol, including the prefrontal cortex, hippocampus, and cerebellum, and
these regions also develop mitochondrial dysfunction and oxidative stress during ethanol use. The central
hypothesis will be tested by pursuing three specific aims: 1) Evaluate subcellular specificity of induction of
CYP2E1 by acute and chronic ethanol in the brain; 2) Determine the role of mitochondria- and ER-targeted
CYP2E1 in mitochondrial effects of chronic ethanol use; and 3) Measure contribution of mitochondria- and ER-
localized CYP2E1 to ethanol-induced oxidative stress. We will pursue these aims using an innovative strategy
of three complementary systems: mice, C. elegans, and cultured cells. In each system we have a null
background lacking CYP2E1, a wild-type CYP2E1 gene targeted to both mitochondria and ER, an ER-targeted
CYP2E1, and a mitochondrial-targeted CYP2E1. The proposed research is significant because it will elucidate
how ethanol metabolism by CYP2E1 changes over a chronic ethanol use paradigm, and could reveal
mitochondrial CYP2E1 as a liability for ethanol toxicity. It is also significant because it generates useful
platforms for studying subcellular localization-dependent effects of CYP2E1. The work will develop
foundational resources that will be used by other researchers. The proximate expected outcome of this work is
an understanding of how CYP2E1 contributes to the effects of ethanol in the brain during chronic and acute
binge drinking. The results will have an important positive impact immediately because they will establish
better understanding of the relationship between ethanol metabolism in brain regions with toxicity, and in the
long-term because they lay the groundwork for identifying therapeutic opportunities.

Public health relevance
PROJECT NARRATIVE Alcohol abuse causes or exacerbates many diseases including neurological disease, and is a leading cause of preventable death in the United States. Much of the toxicity associated with ethanol, including metabolic dysfunction, is due to the production of its reactive metabolite acetaldehyde, which in the brain is produced primarily by the enzymes catalase and CYP2E1. In this proposal, we seek to understand how chronic binge drinking changes acetaldehyde production by CYP2E1 inside brain regions, and the consequences on cellular metabolism and stress.